Decoding the Ubiquitin and Autophagy Signaling Networks

ABSTRACT
The research program described in this proposal focuses on an in-depth exploration of
the ubiquitin and autophagy pathways, which partake in a process called proteome
homeostasis, or proteostasis, and is an essential cellular process. Over the course of this
proposal, our team aims to uncover novel aspects of molecular intricacies of ubiquitin
regulation and to explore the mechanisms underlying selective autophagy in response to
various cellular stimuli. Regarding the ubiquitin machinery aspect of our work, our goal is
to identify and understand the cellular relevance of recently discovered regulatory
switches for ubiquitin signaling. For the autophagy facet of our work, we aim to enhance
our comprehension of singular regulatory factors we’ve identified, which are involved in
this complex biological process. This program combines our expertise in quantitative
mass spectrometry, biochemistry, and cell biology to investigate the different aspects of
proteostasis dynamics and its disruption in proteostasis-related diseases. Our
investigation aims not only to advance scientific knowledge but also to have a substantial
impact on healthcare by reducing our current limitations in understanding disease
mechanisms.

Public health relevance
PROJECT NARRATIVE Dysfunctional ubiquitin and autophagy pathways are pivotal in cellular health. These pathways, crucial for cellular homeostasis, play a significant role in the proper functioning and survival of cells. Our work focuses on investigating the intricacies of pathways involving the ubiquitin and lysosome machinery using quantitative cell biological and proteomics approaches.